Impact of Reduced Cannabis Use on Functional Outcomes

Cannabis Use Disorder (CUD) is associated with a many negative functional outcomes, and unfortunately rates of CUD are increasing in the United States. More than 8 million Americans reported heavy cannabis use in 2013, representing a 59% increase since 2005. Heavy cannabis use (i.e., use on ≥ 40 of last 90 days) is associated with addiction, unemployment, neuropsychological deficits, lower educational attainment, and reduced physical activity. As shown across multiple epidemiologic samples, Black Americans are more likely to misuse cannabis than other racial groups. Heavy cannabis use has increased at an even higher rate among Black Americans. Racial discrimination remains a persistent and significant public health concern, undermining the health of underrepresented groups living in the USA and may be related to inequities in cannabis use and CUD. Racial discrimination is defined as unfair, differential treatment on the basis of race. There is a robust association between the experience of racial discrimination and psychological distress. Current evidence indicate that repeated everyday racial hassles are also associated with psychological distress and physical health. Persons who use cannabis to cope with negative affect are at increased risk of developing CUD. Currently, limited data exist examining the relationship between perceived discrimination and cannabis use outcomes although several recent studies suggest perceived stress and discrimination may be important determinants of cannabis use trajectories. These studies are limited, however, by a reliance on retrospective reports of perceived exposure to discrimination. We propose to supplement our parent project and state-of-the-art ecological momentary assessment (EMA) protocol with multiple measures of perceived discrimination to 1) Evaluate whether exposure to chronic discrimination is related to a) reported cannabis-related problems b) ad lib cannabis use in grams and b) magnitude of cannabis reduction during a four-week intervention period, and 2) Use ecological momentary assessment (EMA) technology to measure the daily association between perceived discrimination and cannabis use. Our central hypothesis for the proposed supplement is that experiences of discrimination and daily perceived unfair treatment will be related to cannabis use outcomes. The rationale for this research is that it will provide the first and only real-time data on this important, but understudied topic. Thus, our findings will directly inform our understanding regarding the effects of past and ongoing racial discrimination on cannabis use and misuse.

Public health relevance
Cannabis Use Disorder (CUD) is associated with many negative functional outcomes, rates are increasing in the US, and Black Americans are more likely to misuse cannabis than other racial groups. We will assess whether racial discrimination is related to CUD.